Metabolic regulation of inflammation during tissue repair

Tissue injury requires the proper establishment of a dynamic inflammatory niche to clear invading pathogens
and damaged cells, and then to promote tissue repair. Clinical cases of poor wound healing are marked by
prolonged inflammation, often associated with immune dysfunction, which leads to tissue damage and a
spectrum of pathological outcomes. Inflammation immediately after injury is largely driven by early-stage
monocyte-derived macrophages and neutrophils, and so understanding the mechanisms that control
inflammation in these cell types will provide new therapeutic treatment options. There is increasing interest in
how changes in metabolism control the phenotypes of macrophages and other immune cells by regulating
signaling and gene expression that are central to activation, including inflammation. Recently, our laboratories
uncovered an unexpected and intriguing role for glutamine metabolism in regulating macrophage function in skin
wound healing. In particular, we found that mice fed glutamine-deficient diets have prolonged inflammation and
defective wound repair. Our data further reveal that glutamine regulates specific subsets of inflammatory genes
and epigenetic changes in macrophages. Therefore, the overall objective of this proposal is to define the
contributions of metabolic regulation of macrophages to skin wound healing. Our central hypothesis is that
glutamine metabolism controls the inflammatory niche during tissue repair in the skin and macrophages are the
primary mediators of this response. This hypothesis is based on our findings that: 1) macrophages display altered
metabolic profiles during early and mid-stage repair; 2) the inflammatory niche is altered in mouse wounds that
lack glutamine metabolism in monocyte-derived cells; 3) glutamine metabolism alters the inflammatory gene
expression of macrophages. Through three focused and complementary Specific Aims, we will (1) identify the
role of glutamine metabolism after injury in vivo and in human macrophages in vitro, (2) define how glutamine
metabolism impacts epigenetic regulation and redox signaling in skin wounds, and (3) examine the impact of
diabetes on glutamine metabolism during skin repair. The work proposed in this application is innovative because
it will take advantage of multiple genetic mouse models that allow specific depletion of glutamine metabolism,
and state-of-the-art genomics and systems analysis of mouse and human wound data. The proposed research
is significant because it will provide information about the precise function of glutamine in skin repair in vivo,
which is currently poorly understood. The rationale for this research is that amino acid enriched dietary
supplementation can improve chronic diabetic wounds, which impacts over 4 million patients in the US and over
7 million worldwide, but more information about the mechanisms is needed to optimize therapeutic applications.
Our proposed studies will identify specific mechanisms that can be utilized to promote healing in human patients
with defective wound healing or inflammatory disorders.

Public health relevance
Project Narrative A thorough understanding of cells and molecules that regulate skin wound healing is essential for developing tissue-specific regenerative therapies to treat human disease. Human metabolic diseases are associated with defects in wound repair, which indicates that nutrient sensing and metabolism regulate healing, but the molecular mechanisms are incompletely understood. Our work will explore how metabolism and amino acid use by immune cells controls wound healing, which will improve our understanding of the cells and molecules that control basic skin repair and have global relevance for other regenerative tissues in patients with inflammatory disorders.